High fidelity low cost manufacture of synthetic DNA

[unreadable] DESCRIPTION (provided by applicant): The long term objective of this project is to develop technology to provide low-cost (<$0.50/bp), rapid synthesis of complete genes (500 bp to 25 kb). Rapid, accurate and affordable gene synthesis will provide a direct link between genomic information and hypothesis-driven experimental science, improving our ability to understand disease processes and design therapeutic agents. Examples of the ways in which gene synthesis can impact health-related projects include codon optimization, splice variant construction and protein engineering for expression of human and pathogen proteins in heterologous hosts for structural genomics, antigen production and use as targets / reporters for drug discovery efforts. Gene synthesis is currently too slow and expensive to meet the needs of the genomic and health sciences community. Current prices are around $2/bp with turnaround times of 3-6 weeks for a gene of 1 kb. The major factors governing price are the costs of building block synthesis and sequence confirmation. The specific aim of this project is to develop methods and machines to synthesize 1-2 pmol of oligonucleotides with isolated purity > 90% and to reliably assemble these into genes. We aim to lower the cost of building block synthesis 3- to 10-fold by combining advanced chemistry with alternative engineering allowing a reduction in reaction volumes and reagent concentrations. It is essential for this application that this reduced cost is accompanied by an increase in quality: lower quality oligonucleotides assemble into genes that have increased error frequencies and thus require additional downstream manipulations and sequence verification, increasing the overall cost of production. We will therefore optimize synthesis on a 2- dimensional support to improve the stepwise coupling efficiency to >99.5%; in Phase I we demonstrated the feasibility of this by obtaining coupling efficiencies of 99.9% using modified chemistries and procedures. Small scale, low cost, high coupling efficiency oligonucleotide synthesis will allow greater flexibility in oligonucleotide gene building block design, remove the need for oligonucleotide purification prior to assembly into complete genes, reduce sequence confirmation costs and shorten order to delivery times. To achieve this, in Phase II we will develop an automated 96 channel instrument for synthesizing oligonucleotides with >90% purity. The machine will be integrated into our existing high throughput gene production line at DNA2.0. A low cost high fidelity oligonucleotide manufacturing process may have additional applications in related areas including diagnostic microarrays, real time PCR and RNAi-reagents. [unreadable] [unreadable]